DP24-004, PRC Core: Arizona Prevention Research Center

Project Abstract:
For 25 years the Arizona Prevention Research Center (AzPRC) has served as a pivotal platform for collaborative
research, training, capacity building, and translation to address health disparities. The overall goal of the
Arizona Prevention Research Center (AzPRC) is to use innovative community-engaged approaches to expand
knowledge, tools, strategies, and resources to achieve greater adoption, implementation, and wide scale use of
EBIs to reduce health inequities. The AzPRC and our partners are committed to championing community
health worker effectiveness in Arizona and beyond. Community health workers (CHWs), inclusive of
promotoras de salud in Latine and community health representatives in American Indian (AI) communities,
are frontline public health workers with a deep understanding and trust within the communities they serve.
Given extensive experience and ties to CHWs, the AzPRC is well-positioned to address social isolation and
loneliness (SIL) through promoting intergenerational connections (IGC). The AzPRC will conduct a core
research project to understand the implementation, translation, and dissemination of CHW supported,
evidence-based strategies to reduce SIL through intergenerational connection. The "Together Across
Generations" core research project will address knowledge gaps surrounding SIL, particularly among rural
border Latine and AI populations, who face severe health inequities in the state and nation. This project is
guided by the Practical, Robust, Implementation, and Sustainability Model and The Transcreation Framework
for Community-engaged Behavioral Interventions to Reduce Health Disparities. Collaborating with
community-based organizations, local health departments, and Tribal nations, the first phase of the study will
assess current social connectedness services and implement evidence-based intergenerational programs. Mixed
methods data from organizations, CHWs, and 120 participants age >55 will be collected in four rural, border
and Tribal sites to examine contextual factors, identify barriers and facilitators, and contribute to the evidence-
base on the cost-effectiveness of these programs. Workshops to support CHW self-care and promote the
sustainability of the workforce will be integrated. Implementation findings will be translated and disseminated
throughout Arizona in the second phase of the project, achieved through partnerships with statewide, local and
Tribal entities that promote equitable public health practices. Dissemination goals, including increases in IGC
programming and improved surveillance of SIL throughout Arizona, will be evaluated through data from
county health departments, federally qualified health centers, and Tribal health organizations. The impact of
IGC services statewide will also be examined with propensity score matching from over 11,000 older adults
who respond to the Arizona Behavioral Risk Factor Surveillance System, with SIL and IGC assessments to be
added. The AzPRC will take leadership in the PRC Network to promote evidenced based practices, national SIL
programming and surveillance, and in promoting the health of the CHW workforce.

Public health relevance
Project Narrative: The Arizona Prevention Research Center (AzPRC) will use innovative community-engaged approaches to expand knowledge, tools, and resources to promote health equity. The AzPRC and partners will conduct a dissemination and implementation research project that uses evidence-based intergenerational programming to address social isolation and loneliness particularly among older adults living in rural, border and Tribal communities. Through Center and research activities and in collaboration with local, state and national partners, the AzPRC will contribute to greater public awareness of the importance of social connection on health, increased screening of SIL in primary care settings, and more equitable access to programs and resources to address SIL in historically neglected communities.